Differential stress responses of organelles to nutritional versus ER stress

Eukaryotic cells can rapidly adjust the abundance, size, and shape of their membrane-bound
organelles in response to physiological needs. We recently found that fission yeast cells employ
different mechanisms to counteract various types of stress: nutritional deprivation sequentially
activates organelle degradation, while ER stress, caused by the accumulation of misfolded
proteins, induces morphological changes in multiple organelles, such as the ER, Golgi, and
mitochondria, without triggering their degradation. Our current research aims to understand the
molecular framework underlying these differential adaptive responses in fission yeast and to
investigate their conservation in mammalian systems. We propose that organelles communicate
and coordinate sequential degradation through selective autophagy. To explore this, we will
integrate structural prediction with genetic and cellular assays to systematically identify selective
autophagy receptors and use multi-omics approaches to investigate potential crosstalk between
organelles during starvation. Given that ER stress is increasingly recognized as a contributing
factor in a number of human diseases including neurodegenerative disorders and cancer, we
will also use fission yeast and human cell cultures to examine how these cells reorganize
multiple organelles to mitigate ER stress. These insights could advance our understanding of
disease pathology and suggest new diagnostic and therapeutic strategies.

Public health relevance
The ability to rapidly adjust the abundance, size, and shape of organelles in response to various stresses is crucial for the function and survival of most eukaryotic cells, yet the underlying molecular mechanisms remain largely unknown. This study focuses on a mechanistic dissection of two distinct stress responses, nutritional stress and ER stress, using fission yeast and human cell cultures as model systems. Expected findings may offer new insights into the pathology of various diseases and suggest novel avenues for therapeutic intervention.